Retinal microvasculature as a predictor of neurodegeneration in multiple sclerosis

Objectives: Multiple Sclerosis (MS) is a chronic inflammatory and neurodegenerative illness that affects nearly
1 million people in the United States. Currently, there are no FDA-approved treatments that directly address
neurodegeneration and its associated clinical impairment. Systemic vascular disease comorbidities, including
hypertension, hyperlipidemia, and obesity, independently worsen MS-related walking limitations. In addition, MS
pathology demonstrates microvascular dysfunction in the central nervous system (CNS). Our working model is
that CNS vascular dysfunction accelerates neurodegeneration and thus limitations in activity and health-related
quality of life. The purpose of this study is to quantify CNS vasculopathy in people with MS through
microvascular changes in the retina as a first step to identify treatable modifiers of neurodegeneration.
The overall study hypothesis is that retinal microvascular changes, measured by optical coherence tomography
angiography (OCTA), in people with MS will correlate with patient-reported and objective measures of
neurodegeneration. The long-term goal is to use OCTA as a surrogate of vascular dysfunction in trials of
neuroprotective therapies.
Plan: This is an observational study. The study procedures include a standard battery of neurologic and visual
clinical exams to assess participant function, questionnaires to assess participant quality of life, and OCTA to
assess CNS vasculature through the retina.
Methods: This 2-year prospective cohort study features cross-sectional and longitudinal analyses to compare
the impact of vascular comorbidities on retinal vascular density, determined by OCTA, as a measure of
neuronal structural and functional integrity. Study MRI data will be collected at baseline and 2 years. We will
enroll 44 subjects (accounting for 25% drop out for longitudinal aims) with a goal of 34 MS subjects with and
without vascular comorbidities (V+, V- respectively). Data from an additional 22 healthy controls has already
been collected and will be included for analysis. Subjects will be aged 30-70 and will be matched by age,
gender, and use of disease modifying therapies. The primary outcome is to compare retinal vascular density in
V+ and V- Veterans through cross-sectional analysis (Specific Aim 1). We will also explore if retinal vascular
density correlates with increased rate of brain atrophy in V+ compared to V- Veterans (Specific Aim 2).
Importantly, we will also determine if clinical impairment and quality of life deteriorates faster in V+ versus V-
Veterans (Specific Aim 3).
Relevance to VA’s Mission: The proposed study will have a profound impact on our Veteran population: of
the 28,000 Veterans receiving care for MS within the VA system, approximately 50% have at least one
vascular disease comorbidity. Since many of these comorbidities are modifiable, early identification of vascular
dysfunction provides a window of opportunity for early interventions to optimize activity, participation and
health-related quality of life. The VA Portland Health Care System (VAPORHCS) is an ideal place for my
training program. We provide care for over 500 Veterans with MS annually. Additionally, we are one of only two
national MS Centers of Excellence (MSCoE West) within the VA. With this designation, we have a particular
dedication to setting the standards for clinical care, education, and high-quality collaborative research for
Veterans with MS. Using the network of VA MS Clinics coordinated through the two VA MSCoE, findings from
this study can be translated into improved care of all Veterans with MS. Through this experience, I will also
gain the necessary skills in visual outcomes, statistical analysis, trial design, and team leadership to allow me
to become a national leader in rehabilitation research and to ultimately improve the quality of life of Veterans
with MS.

Public health relevance
Multiple sclerosis (MS) is a chronic disease that causes swelling, or inflammation, and cell death in the brain and spinal cord. Blood vessel damage in the brain is important in both active inflammation and neuron death in MS. In addition, people with MS with vascular disease comorbidities, like high blood pressure and high cholesterol, have more disability. Over time, this death of neurons leads to limitations in patient participation and health-related quality of life. This study explores the relationship between blood vessel disease in the brain, neuron death, and clinical limitations in MS. We will follow people with MS with and without vascular disease comorbidities for 2 years to study how clinical performance and brain imaging changes across time. My long-term goal is to develop and study treatments that address MS-related blood vessel disease in order to protect the brain against cell death and ultimately improve the lives of Veterans living with MS.